Modular Sample Preparation for In-Field Viral Discovery

TO DESIGN AND DEVELOP A NOVEL APPROACH TO EFFICIENTLY COLLECT SAMPLES (E.G., BLOOD) IN FIELD LOCATIONS TO SUPPORT SURVEILLANCE ACTIVITIES TO IDENTIFY NEW VIRUSES OF PANDEMIC POTENTIAL.